Hydrogel Targeting of Organ Specific Gene Therapy

PROJECT SUMMARY/ABSTRACT
Gene therapy is a promising therapeutic strategy to treat human diseases. While vectors can be
engineered to target specific cells, the blood flow greatly favors liver and lung exposure. Delivery of vectors to
confined anatomic compartments such as the eye and central nervous system, or ex vivo to cells that are
modified than re-administered, are strategies successful in approved gene therapies. Many other organs
cannot be effectively targeted using current vector systems. Gene therapy for heart disease has failed in
clinical trials due in large part to low transduction of cardiomyocytes reported as 1% of cells. Coronary blood
flow is very robust and intracoronary vector has little time to access cardiac cells. In the blood stream, vector
is vulnerable to detection by pre-existing anti-AAV neutralizing antibodies that are present in up to 90% of the
population. These obstacles, along with the high cost of producing vector limits the efficacy and translatability
of cardiac gene therapy. The fundamental problem of therapeutic gene delivery is the focus of this proposal.
Our interdisciplinary multi-PI team will approach gene therapy from a novel bioengineering approach,
developing hydrogels to traverse biological barriers to vector delivery. We will engineer a hydrolysis-cleavable
poly(-ethylene glycol, PEG) hydrogel to deliver gene therapy vectors to the epicardium. Our preliminary data
support the idea that this mode of delivery will optimize cardiac transduction. We have previously
demonstrated the efficacy of PEG hydrogels and validated a hydrogel delivery device that is able to deliver
hydrogels in a minimally invasive and fast procedure using standard fluoroscopy. Our multi-PI team includes
Rebecca Levit, a physician scientist with extensive expertise cardiac therapeutics and small animal models,
Andrés García, an engineer and expert on biocompatible hydrogels, and Christopher Doering, a gene therapist
with a track record of development, translation, and manufacturing of gene therapies.
This project is organized to efficiently and rapidly assess this novel mode of delivery of gene therapy. In
aim 1 we will test 6 hydrogel prototypes in vitro and in vivo to determine the most efficient formulation for vector
delivery. In aim 2 we will quantify the immunologic advantages of epicardial hydrogel vector delivery to predict
the performance of this strategy in patients. In aim 3 we will deliver a unique candidate gene for cardiac
regeneration as proof of principle of our epicardial hydrogel delivery strategy. We hypothesize that epicardial
hydrogel gene therapy can overcome fundamental circulatory and immunologic barriers to therapeutic gene
delivery. These studies will result in a clear translational path for gene therapy.

Public health relevance
PROJECT NARRATIVE Many diseases are treatable with gene therapy, but it is difficult to target specific organs and large doses of vector are used to overcome this off-target loss. In this multi-PI project, we will develop a novel platform to enable cardiac gene therapy by encapsulating viral vectors in hydrogel delivered to the epicardium. These studies will test the ability of this strategy to minimize effective dose, overcome immune neutralization, and repair cardiac damage, validating it for clinical use.